Bioinformatics Core

Project Summary – Bioinformatics Core C
The Bioinformatics Core will conduct bioinformatics and statistical analyses of data generated by the projects
and cores to address research hypotheses defined in the project-specific proposals. The core will also perform
integrative analyses to combine data from all experiments. The PDX Core will provide central storage, data
management and information security for generated raw and processed high throughput data within the PDX
Development and Trial Center (PDTC). The core will assist with preparation and writing of progress reports,
abstracts, manuscripts, and future research proposals. During the span of the Research Program, the
Bioinformatics Core will ensure timely progress tracking of PDX trials and sharing of generated results between
members of the PTDC.